Optimizing Mealtime Care (OPTIMAL): Development and Pilot Testing of a Person-Centered Mealtime Care Intervention for Nursing Home Residents with Alzheimer's Disease and Related Dementias (ADRD)

Project Summary/Abstract – Funded/Parent Project
The overall goal of this Mentored Patient-Oriented Research Career Development Award (K23) is to support
the candidate, Dr. Wen Liu, in developing an independent clinical program of research to optimize mealtime
care quality, function, and nutrition in aging and ADRD population. Her long-term career goal is to become an
independent investigator and national leader conducting patient-centered, interdisciplinary clinical research to
optimize mealtime care and patient outcomes across a broad range of care settings. Dr. Liu’s three training
goals are: 1) Behavioral intervention science to develop knowledge and skills on the development, delivery,
evaluation, and refinement of behavioral interventions for dementia mealtime care in clinical care settings; 2)
Advanced methodologies in clinical trials to develop knowledge and skills in a) design and conduct of
clinical trials, and b) the use of qualitative and mixed methods to inform feasibility of the intervention and guide
refinement of the intervention; and 3) Advanced quantitative statistical methods to analyze large clustered
data coded from video-taped mealtime observations that are collected from behavioral clinical trials. Under the
mentorship of an accomplished team of investigators, Dr. Liu will achieve the training goals through completion
of systematically planned formal and informal training activities at the University of Iowa, a research-intensive
organization with significant and long-standing resources for early career investigators. The training plan will
provide her with knowledge and skills necessary to address two significant and intertwined dementia mealtime
care problems - mealtime difficulties and insufficient intake - both requiring immediate and joint resolution.
Emerging evidence supports the negative association of full assistance provision and the positive association
of person-centered care with resident mealtime difficulties and intake. Current interventions are lacking on the
use of person-centered care strategies, and fail to address care providers’ needs for knowledge and skills to
provide optimal mealtime care. To address this gap, the proposed research aims to complete the development
and pilot testing of a theory-based, person-centered mealtime care intervention, Optimizing Mealtime Care
(OPTIMAL), to effectively engage residents in eating and maintain their highest level of function possible. The
three specific aims are: 1) Develop, evaluate, and refine the OPTIMAL intervention protocol and training
materials; 2) Determine feasibility, fidelity, and usefulness of OPTIMAL; and 3) Describe resident
outcomes. This study will use a mixed methods approach integrating focus group interviews and a pilot two-
group parallel cluster RCT. Data obtained will be used to further refine the OPTIMAL intervention protocol and
study procedures, as well as to estimate effect sizes for a future larger trial. Dr. Liu will develop and submit an
R01 application to evaluate the efficacy of the refined OPTIMAL by middle of Year 4. This study is a critical first
step to achieve Dr. Liu’s long-term career goal, and complements the NIA strategic focus to support and
conduct behavioral research to improve health, well-being, and function in the aging and ADRD population.
Project Summary/Abstract - Administrative Supplement
The PI has experienced a critical life event during the award period, which along with pandemic-related delays
and challenges has impacted the progress of the funded project and increased the needs for more time and
personnel support for the completion of the remaining study activities of the funded project. The administrative
supplement is critical to provide 1-year personnel support for a full-time research support coordinator and
research assistants in the team. The support will be critical to ensure the continuity of the research project and
collaboration of the currently established research team who have been well trained with study procedures,
have a good understanding of the data collected and procedures to complete remaining activities, and have
been working collaboratively with the PI in the previous year.
The administrative supplement will be used to support the research team members to complete the following
activities which are within the scope of the funded project:
1. Ongoing research activities in Aim 2 and Aim 3 including data coding, cleaning, entry, and
management; development of multi-level data structure/datasets, and data analysis.
2. dissemination of results through manuscripts, presentations, stakeholder/community engagement
activities, and other sources
3. preparation and submission of a large R-series grant application to NIH/NIA.
Support from the administrative supplement will greatly ensure the successful completion of the remaining
activities of the funded project. Completion of these research activities will support the continuity of the PI (Dr.
Wen Liu)’s program of research in dissemination of person-centered care to optimize mealtime care and
outcomes in ADRD, support the PI to return to full productivity at the end of the supplement period, and
facilitate PI’s transition from mentored career development award to research independence.

Public health relevance
Project Narrative – Funded/Parent Project Despite the recognized increased risks and consequences of mealtime difficulties and insufficient intake, people with ADRD are not provided with optimal person-centered mealtime care to manage the two interrelated and important health care problems (i.e., mealtime difficulties, insufficient intake). Developing an effective behavioral intervention that integrates person-centered mealtime care and management of risks of inadequate intake and malnutrition will address a significant long-term care need in adults with ADRD in diverse care settings, because such an intervention may have great potential to decrease mealtime difficulties, optimize intake, and improve nutrition and quality of life which are fundamental health needs as cognition declines. As a logical first step in intervention development and testing, data obtained from the proposed study will provide critical information to guide the refinement of the intervention protocol and clinical trial procedures and to estimate effect sizes for sample size calculation, which will be used in a future large-scale clinical trial that aims to evaluate the efficacy of OPTIMAL on resident outcomes (e.g., mealtime difficulties, intake). Project Narrative – Administrative Supplement The PI has experienced a critical life event during the award period, which along with pandemic-related delays has impacted the progress of the funded project and increased the needs for more time and personnel support for the completion of the remaining study activities of the funded project. The administrative supplement support is critically needed to provide 1-year personnel support for a full-time research support coordinator and research assistants who have been working collaboratively with the PI and well trained to complete the remaining activities of the funded project. The administrative supplement support will ensure the continuity of the PI (Dr. Wen Liu)’s program of research in dementia mealtime care, support the PI to return to full productivity at the end of the supplement period, and facilitate PI’s transition from mentored career development award to research independence.